Mechanisms of Retinogenesis in Human Stem Cells

DESCRIPTION (provided by applicant): Inherited and acquired diseases of the neural retina (NR) and/or retinal pigment epithelium (RPE) are a significant issue in human health and quality of life. Stepwise retinal differentiation of human pluripotent stem cells (hPSCs) can provide a model system to study human retinal development and supply cells for the potential treatment of debilitating retinal diseases. We have shown that two types of hPSCs, human embryonic stem cells (hESCs) and human induced pluripotent stem cells (hiPSCs), can differentiate along the retinal lineage in a manner that closely parallels normal human retinogenesis. However, little is known about the factors and events that influence key steps in the differentiation of these cell types from hPSCs. Our long-term mission is to define molecular mechanisms of retinal cell fate determination from hPSCs and apply this knowledge to the study and treatment of human developmental and degenerative retinal disorders. An important step in vertebrate retinogenesis occurs during the optic vesicle (OV) stage, when cells make the seminal decision to develop either as a neural retinal progenitor cell (NRPC) or an RPE cell. VSX2 is the earliest known marker of NRPCs and is hypothesized to pattern the naove OV into the NR and RPE domains by repressing expression of the early RPE-associated gene MITF. Disruption of Vsx2 expression in animal models by various means causes severe defects of the eye and retina, and humans with mutations in this gene exhibit microphthalmia and malformed retinas. Despite the critical roles attributed to VSX2 during retinal development, there is scant information available on its mechanisms of action and regulation in humans. Our unique capability to culture human cell populations from the earliest stages of retinogenesis and to isolate OV- like structures provides a pertinent in vitro model system to study VSX2 function in human retinal cell development. The primary objectives of this proposal are to a) determine the purpose and necessity of VSX2 in the initial production of retinal cell types from hPSCs and b) identify endogenous hPSC signaling mechanisms that control VSX2 expression during differentiation. Experiments are designed to investigate the overall hypothesis that VSX2 expression in hPSC-derived retinal cultures leads to maintenance of a proliferating pool of NRPCs at the expense of RPE. To test this theory, we will pursue the following specific aims: 1. Determine the gene regulatory roles and mechanisms of VSX2 during the early production and proliferation of NRPCs in differentiating hPSCs. 2. Define the ligands and pathways that mediate the reciprocal effects of FGF and TGF2 signaling in the regulation of early VSX2 expression in differentiating hPSCs. 3. Determine the effects of a naturally occurring, human VSX2 mutation on the establishment and expansion of NRPC vs. RPE cell populations using patient-derived hiPSCs.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of this proposal is to advance understanding of the development of the human retina. By using our stepwise method to coax stem cells to become a full range of retinal cell types in a culture dish, we can model how the building blocks of the human retina are produced, beginning at their most primitive stages. Such a model will have great value in the study of basic mechanisms of retinal development and the causes of inherited eye diseases, and will complement our efforts to develop cell-based therapies for degenerative retinal disorders. PROJECT NARRATIVE The purpose of this proposal is to advance understanding of the development of the human retina. By using our stepwise method to coax stem cells to become a full range of retinal cell types in a culture dish, we can model how the building blocks of the human retina are produced, beginning at their most primitive stages. Such a model will have great value in the study of basic mechanisms of retinal development and the causes of inherited eye diseases, and will complement our efforts to develop cell-based therapies for degenerative retinal disorders. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Disorders resulting from the congenital absence or postnatal degeneration of cells within the neural retina (NR) and/or retinal pigment epithelium (RPE) cause profound and permanent vision impairment in millions of individuals. Recent observations suggest that human pluripotent stem cells (hPSCs) can be used to model and perhaps ameliorate some conditions affecting neural retinal (NR) cells and RPE1-4. However, little is known about the factors and events that influence key steps in the differentiation of these cell types from hPSCs. Our long-term mission is to define molecular mechanisms of retinal cell fate determination from hPSCs and apply this knowledge to the study and treatment of developmental and degenerative retinal disorders. One of the earliest and most important steps in vertebrate retinogenesis occurs during the optic vesicle (OV) stage, when cells face the seminal decision to develop either as a neural retinal progenitor cell (NRPC) or an RPE cell. Conspicuous in this process is the expression of the Visual system homeobox 2 protein (VSX2, also called CHX10). VSX2 is the earliest known marker of NRPCs and is present in these cells throughout retinal development5-7. In vertebrates, Vsx2 is expressed initially in the distal OV in response to inducing factors secreted by the overlying surface ectoderm and by the OV as well8-9. At this early stage, Vsx2 is thought to pattern the naïve OV into the NR and RPE domains by direct repression of the early RPE- associated gene MITF8-10. In addition, Vsx2 appears to modulate NRPC proliferation by indirect regulation of the cell cycle inhibitor p27kip1 11. Disruption of Vsx2 expression in animal models causes severe defects of the eye and retina, ranging from small eyes with NR hypoplasia and dysplasia to frank duplication of the RPE layer in conjunction with NR loss10, 12-15. Evidence of the importance of VSX2 in human retinogenesis comes from patients with mutations in the gene, which result in very small, nonfunctional eyes with correspondingly maldeveloped retinas16-18. Affected individuals have a purely ocular phenotype17, reflecting the restricted tissue expression of VSX2 and the secondary effects of its dysfunction on global eye development. Despite the critical roles attributed to Vsx2 during retinal development, information on its mechanisms of action and regulation in humans is nearly nonexistent. Such deficiencies are due to inherent difficulties isolating and culturing cell populations at the initial stages of human retinogenesis. Pluripotent stem cells have the potential to recapitulate many, if not all, stages of cellular development, and thus may provide a means to study mechanisms of early human retinal differentiation in depth. Recently, we demonstrated that two types of hPSCs, human embryonic stem cells (hESCs) and human induced pluripotent stem cells (hiPSCs), can differentiate along the retinal lineage in a manner that closely parallels normal retinogenesis19. Early during this process, near uniform expression of VSX2 was found in a subpopulation of cell aggregates that possessed numerous characteristics of the OV. These "OV-like bodies" adopt a vesicular structure in suspension culture that allows them to be visibly distinguished and manually separated from non-retinal spheres. Additional investigation revealed that VSX2+ OV bodies were highly proliferative and gave rise to all NR cell types in a developmentally appropriate sequence and time frame, which further identified them as multipotent NRPC cultures. By contrast, lack of VSX2 expression in rare OV bodies correlated with maintenance of MITF expression and production of RPE. Our unique capability to isolate and culture human cell populations at the earliest stages of retinogenesis opens the door for the detailed study of VSX2-mediated mechanisms involved in NRPC vs. RPE fate determination. The primary objectives of this proposal are to a) determine the purpose and necessity of VSX2 in the initial production of NRPCs and RPE from hPSCs and b) identify endogenous hPSC signaling mechanisms that control early VSX2 expression. Experiments are designed to investigate the overall hypothesis that the early expression of VSX2 in hPSC-derived retinal cultures leads to production of a proliferative pool of NRPCs at the expense of RPE. To test this theory, we will pursue the following specific aims: 1. Determine the gene regulatory roles and mechanisms of VSX2 during the early production of NRPCs in differentiating hPSCs. 2. Define the ligands and pathways that mediate the reciprocal effects of FGF and TGFβ signaling on the regulation of early VSX2 expression in differentiating hPSCs. 3. Determine the effects of a naturally occurring, human VSX2 mutation on the establishment of NRPC vs. RPE cell populations using patient-derived hiPSCs. The successful pursuit of these aims will advance our understanding of the mechanisms and signaling pathways controlling the generation of NRPCs and RPE from clinically relevant, human cell sources. In addition, it will provide a novel and versatile foundation to study human retinal development and inherited disease, thus improving the utility of hPSCs in both basic and translational retina research.